ROAMM-EHR: Pilot Trial of a Real-Time Symptom Surveillance System for Post-Discharge Surgical Patients

Project Summary
In recent years, mobile health (mHealth) apps have promised improved monitoring of health conditions to
improve clinical outcomes. While existing sensors and devices collect relevant information from patients, such
information is rarely shared with healthcare providers, potentially preventing timely interventions. Existing
patient portals are typically static in nature— they lack remote and real-time capabilities for monitoring
symptoms, medication use, activity levels and community mobility. These is vital information for understanding
how patients recover from surgical procedures— this is particularly true for older adults who are highly
vulnerable to poor recovery. The objectives of this application are to: 1) implement our existing Real-Time and
Online Assessment and Mobility Monitor (ROAMM) smartwatch app platform into the electronic health record
(EHR) to form the ROAMM-EHR platform and 2) test its feasibility in a pilot randomized clinical trial (RCT) in
older patients (n= 50, >60 yrs) discharged after orthopedic surgery in preparation for a definitive trial. The
central hypothesis is that integrating patient generated health data with the EHR system will improve symptom
management and carry over into better outcomes, e.g. mobility function, lower pain, and better quality of life
indices compared to the standard of care. The rationale is that ecological momentary assessment of patient
symptoms can promote earlier and more informed micro-interventions such as changing medications,
enhancing rehabilitation or performing more check-ins, resulting in improved patient outcomes. The pilot RCT
will accomplish operational aims to refine and establish several elements for the future trial, including: the
onboarding and behavioral approaches for using ROAMM-EHR, randomization scheme, study outcomes,
quality assurance and standardization, recruitment and retention rates, data analytic strategies, technical
implementation, and patient and staff usability/acceptability. The approach is innovative, because study will
represent the first effort to not only build and implement but also to formally test a real-time post-surgical
symptom surveillance platform by integrating patient generated health data from wearable devices with the
EHR system. The proposed research is significant since timely post-surgical recovery will prevent both long-
and short-term poor outcomes in older adults. The expected outcomes are 1) a new smart watch enabled
symptom surveillance platform that will facilitate post-surgical care management and 2) the necessary
knowledge for planning a definitive trial to reduce the major gap of evidence-based medicine for mHealth
interventions. At its completion, the implementation and rigorous evaluation of ROAMM-EHR will not only test a
transformative clinical tool, it will serve as a foundation for others in both public and private sectors who strive
to capitalize on the promise of mHealth apps in healthcare.

Public health relevance
Project Narrative The proposed research is relevant to public health because it can result in enhanced patient care workflow and early intervention, ultimately improving patient outcomes and decreasing healthcare costs. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to advancing disease diagnosis through medical applications of new tools and technologies, as the proposed research applies advanced technologies to provide real-time surveillance of post-discharge symptoms in surgical patients in real-time.